POST-BACCALAUREATE TRAINING IN INFECTIOUS DISEASE RESEARCH

The University of Georgia (UGA) proposes a renewed program in “Post-baccalaureate Training
in Infectious Diseases Research” (PREP@UGA) in response to the call for Post-baccalaureate
Research Education Program R25 proposals. UGA is strongly committed to enhancing diversity
at all levels, and has made major strides in recruiting and successfully graduating students
belonging to historically underrepresented groups, including racial and ethnic minorities and
students with disabilities. To date, PREP@UGA has trained 20 past and current scholars, with
11 of 12 graduates currently in PhD programs at Carnegie Foundation classification “Doctoral
University - Highest Research Activity” institutions. PREP@UGA will continue to draw on UGA’s
remarkable strength in infectious diseases research, as well as strong graduate programs in
several of its biology-related departments and collaborative affiliates, to provide intensive
research experiences for eight underrepresented minority and disabled trainees each year.
Forty-five faculty from the departments of Biochemistry and Molecular Biology, Cellular Biology,
Ecology, Engineering, Entomology, Environmental Health, Forest Resources, Genetics,
Infectious Diseases, Mathematics, Microbiology, and Population Health, will incorporate
PREP@UGA scholars into their laboratories, providing a unique, structured and mentored one-
year research experience. Coupled with a number of PREP-specific and integrative (with PhD
student) group activities, the latter enriched by NIH T32 training programs in Genetics,
Glycoscience and Tropical and Emerging Global Diseases, a pending IMSD program, and
existing programs designed to enhance and support the success of graduate students
belonging to underrepresented groups, these research experiences will provide trainees with
skills and attributes and build the sense of community that is essential for retention of UR
students in the biosciences. Each trainee will be guided by a specifically designed,
individualized development plan to further enhance development of these skills and attributes,
with guidance by a mentoring team, the support of a personal mentor, and access to the
National Research Mentoring Network. The UGA PREP will recruit well-qualified candidates
from UGA programs as well as via networks with undergraduate advisors and graduate
coordinators established by PREP@UGA faculty, Directors, and the UGA Graduate School to
ensure that the program trains young scientists who are committed to a career in biomedical
research and who need to gain addition research experience and academic credentials to
achieve this goal.

Public health relevance
There is a significant need for diversity in the field of biomedical research. Underrepresented minorities and persons with disabilities often face insurmountable challenges that preclude their entrance into scientific graduate training, leading to this lack of diversity. The University of Georgia’s Post-baccalaureate Training in Infectious Diseases Research Program will provide intensive research training experiences to recent post-baccalaureate underrepresented minority and disabled students as an avenue for these students to gain the skills and attributes necessary for gaining admission to biomedical graduate programs and attaining success careers in biomedical research.